Direct CNS Delivery System for BDNF AntagoNATs using Heterotopic Mucosal Grafting for the Treatment of Parkinson's Disease

PROJECT SUMMARY
The most significant obstacle in the treatment of neurological disorders is the blood-brain barrier (BBB) which
prevents 98% of all potential neuropharmaceuticals from reaching the central nervous system (CNS). Brain
derived neurotrophic factor (BDNF) is one of the most intensely studied targets in Parkinson’s disease (PD) as
it can reverse disease progression. BDNF AntagoNATs are synthetic oligonucleotide-like compounds capable
of upregulating endogenous BDNF expression. AntagoNATs solve the problems of recombinant BDNF
therapies including off-target toxicity, immunogenicity, and improper post-translational modification while
increasing target specificity, improving neuronal uptake, and providing appropriate subcellular
compartmentalization of the expressed protein. Compounds chemically similar to AntagoNATs have been
shown to be safe and have been recently FDA approved. Despite the significant promise of BDNF AntagoNAT
therapies for PD, they cannot cross the BBB. Current methods to bypass the BBB are expensive, have
significant complications, and cannot be easily scaled. The trans-nasal pathway to bypass the BBB holds
significant promise however current techniques rely on diffusion through the olfactory mucosa and have major
drawbacks including a restricted surface area, variable drug contact, unpredictable pharmacokinetics, limited
mucosal residence time, and poor drug stability. This innovative proposal brings together a unique, multi-
disciplinary team of experts to overcome each of these challenges. Our group has developed an innovative
intranasal heterotopic mucosal grafting technique capable of delivering a wide range of high molecular weight
therapeutics directly into the CNS. This method is based on established endoscopic skull base procedures that
have been safely performed globally for over a decade. We have previously shown that the BDNF AntagoNAT
therapeutic strategy is non-immunogenic, reduces off target toxicity, overcomes the limitations of recombinant
neurotrophic protein delivery, and is capable of successfully upregulating BDNF expression in critical end
organ targets following transmucosal delivery. We have further demonstrated that the mucosal grafting
technique is safe, cost effective, and highly scalable. Finally, our data indicate that our dual-compartment
Liposome-in-Gel (LiG) delivery system is capable of protecting oligonucleotide cargo while improving CNS
distribution by providing a sustained release depot at the mucosal surface. Our overall goal is to optimize the
LiG formulation, create a quantitative pharmacokinetic model of transmucosal BDNF AntagoNAT delivery using
LiG, and validate the therapeutic efficacy in two complementary rodent models of PD using histologic,
behavioral, and live imaging endpoints. This innovative delivery system for BDNF AntagoNATs represents a
platform technology which can eliminate the BBB as a fixed barrier to delivery and enable the use of
AntagoNATs in the treatment of multiple currently undruggable CNS disorders. Our proposal is specifically
designed to gather the critical pre-clinical data needed to provide a rapid pathway to first-in-human trials.

Public health relevance
NARRATIVE Brain Derived Neurotrophic Factor AntagoNATs are oligonucleotide based therapeutics which could significantly transform the treatment of Parkinson’s Disease but cannot cross the blood-brain barrier. This proposal seeks to develop a novel lipsome-in-gel sustained delivery system using intranasal mucosal grafting to deliver AntagoNATs directly to the brain. This platform technology has the potential to dramatically improve the therapeutic landscape for Parkinson’s Disease as well as a host of other neurodegenerative diseases.